A Culturally Adapted Sleep Intervention Program for Older Asian Immigrants with Limited English Proficiency

Project Summary/Abstract
Poor sleep is common among Asian Americans. Untreated sleep problems increase the risk of chronic
diseases, cognitive decline, and mortality. Cognitive behavioral therapy for insomnia (CBTI) is considered the
first-line treatment for chronic sleep problems and has demonstrated significant improvement in sleep health
among older adults. However, existing CBTI is built upon Western culture, making it challenging to apply for
Asian immigrants who maintain close ties to their native cultures that shape and influence their sleep habits.
Addressing the lack of availability of a culturally adapted sleep intervention program is the first step to filling the
gap in sleep health disparity among Asian immigrants.
The current proposal aims to develop a culturally adapted sleep intervention program for older Korean
immigrants with poor sleep and to evaluate its feasibility and preliminary efficacy. In Year 1 of the project, using
the cultural adaptation strategies guided by Barrera and colleagues and prior studies, we will refine an existing
behavioral sleep intervention program built upon the core components of CBTI with input and feedback from
key stakeholders and older Korean immigrants in a community setting. Next, we will train a sleep educator to
deliver the intervention at a community-based agency serving older Korean immigrants. In Year 2 of the study,
we will conduct a pilot randomized clinical trial in which the study participant (N=32) will be randomized to
either (a) our culturally adapted sleep intervention group or (b) the control group (general sleep education
only). We will evaluate the feasibility of the intervention and the preliminary effects of the intervention on sleep
health outcomes among Korean immigrants.
The knowledge gained from this study can potentially improve the lives of Asian immigrants with poor sleep. If
our sleep intervention program is acceptable and feasible for delivery in the community setting and shows
superior clinical outcomes compared to the control group, the preliminary findings will pave the way for a larger
clinical trial to examine the efficacy of the sleep intervention in the long term. The intervention manual is
scalable and can be easily delivered by staff in various community settings. It also has the potential to increase
its accessibility and adherence to the intervention recommendation.

Public health relevance
Project Narrative This study aims to develop a culturally adapted sleep intervention program and to evaluate its feasibility and preliminary efficacy for older Korean immigrants with poor sleep, one of the fastest-growing immigrant groups in the United States with limited access to mainstream sleep therapies. The intervention will be based on the core components of an existing cognitive behavioral therapy for chronic sleep problems and finalized in an iterative, cultural adaptation process. Improved sleep health through such intervention in this subgroup of Asian immigrants may lead to a way to address sleep health disparities among Asian Americans.